Spatiotemporal Alterations of Thalamocortical Circuitry Functioning Underlie Pain

SUMMARY
Pain is a highly debilitating condition that is complex and difficult to manage. The neural basis of pain involves
alterations in thalamocortical (TC) circuitry functioning, which can manifest as TC dysconnectivity and
dysrhythmia (especially, impaired alpha oscillations). While likely reflecting inherently coupled (spatial and
temporal) aspects of TC circuitry dysfunction, to date, TC dysconnectivity and dysrhythmia have only been
examined independently, precluding fundamental understanding and effective intervention of this important
pathology of pain.
Capitalizing on our fully developed multimodal neuroimaging methodology (simultaneous EEG-fMRI and
combined EEG-MEG-fMRI) and transcranial alternating current stimulation (tACS), the current R01 aims to
address this critical gap. Aim 1 (Expt. 1) will directly link the spatial (via fMRI TC connectivity) and temporal
(via EEG/MEG alpha oscillations) aspects to demonstrate coupled spatiotemporal alterations in TC circuitry
functioning in experimental (tonic) and clinical (chronic low back) pain. Aims 2 & 3 will causally unify and
upregulate the coupled spatiotemporal TC circuitry functioning in experimental and clinical pain, as causal
manipulation of one aspect (TC dysrhythmia) via tACS of alpha oscillations (α-tACS) induces TC-circuit-wide
functional restoration. Implementing a rigorously controlled experiment with a double-blind, double-controlled
(active and passive control), crossover tACS design (Expt. 2), Aim 2 will establish an experimental model of
this hitherto unexplored mechanism of pain. Through four weeks of α-tACS among patients with chronic low
back pain (Expt. 3), Aim 3 will ascertain this unified TC circuitry pathology of pain (and reveal potential
therapeutic effects of neuromodulation of alpha oscillations).
Leveraging special but complementary expertise and facilities of our two labs, the three Aims pursue a broad
and in-depth investigation, translating basic experimental insights into mechanistic understanding of acute and
chronic pain. The project also emphasizes rigor and reproducibility through parallel recruitment of large and
diverse samples (200 healthy participants and 140 patients) and multi-point cross/within-site validation and
integration. Findings from this project will cast a “new look”—a unified spatiotemporal account—on TC
pathology of pain and hence inspire novel pain treatments.

Public health relevance
NARRATIVE Leveraging multimodal neuroimaging and neuromodulation, this study aims to unify spatiotemporal alterations in thalamocortical circuitry functioning in both experimental and clinical pain. It will produce novel mechanistic evidence to advance the conceptualization and treatment of pain.